Multimodal classification and sub-cellular compartmentalization of displaced amacrine cells in the mouse retina

PROJECT SUMMARY
Among the 5 classes of neurons in the mouse retina (photoreceptors, horizontal cells, bipolar cells, amacrine
cells, and retinal ganglion cells), our field has achieved complete or nearly complete classifications of all but the
amacrine cells. One goal of this project is to fill part of this gap in knowledge by establishing a multimodal
classification of displaced amacrine cells (dACs). However, unlike many other types of neurons, amacrine cells
(ACs) either have no axons or they have multiple axons that may transmit different information to different
locations. Thus, a second goal of this project is to go beyond somatic recordings to measure the subcellular
compartmentalization critical to revealing the role amacrine cells play in retinal circuits.
We have measured light responses, intrinsic electrical properties, and morphology from over 100 dACs and
clustered them into 21 types. In Aim 1, we will align these morpho-electric types to transcriptomic clusters from
the published single-cell RNA-seq databases. In Aims 2 and 3, we will use two-photon calcium imaging to
measure functional compartmentalization within dAC neurites.
The successful completion and publication of this project will have major impacts on retinal neuroscience. As we
did for RGCs at rgctypes.org, we will create a website to disseminate our multimodal dAC classification data,
providing a common foundation for future work across labs. Our biophysical and functional measurements of
compartmentalization in dACs will combine with existing and emerging connectomic data, leading to a more
complete understanding of their roles in many circuits. In Aim 3, we will use orientation selectivity as a model for
a computation that may take place at the level of neurites rather than at the level of an integrated signal in the
soma.
Ultimately, revealing the roles of amacrine cells in retinal computation will help us understand their dysfunction
in disease. The high degree of conservation of these cells from mice to humans suggests that some of the circuits
we discover may translate to new interventions for blinding diseases in patients.

Public health relevance
PROJECT NARRATIVE Amacrine cells are the final remaining neuron class in the retina in which there are substantial gaps in our knowledge of cell types, and this project will fill part of this gap in knowledge by establishing a multimodal classification of displaced amacrine cells. Amacrine cells are also among the most important examples of subcellular compartmentalization in neuroscience, so a second goal our project is to reveal how they compartmentalize function in different parts of their neuritic arbors. Revealing the identities of amacrine cell types and their roles in retinal computation will help us understand their dysfunction in disease.